Biology and structure of pMHC receptors functioning as mechanosensors in the [alpha][beta] T-cell lineage

ABSTRACT – OVERALL
T lymphocytes utilize  T cell receptors (TCRs) to distinguish self from non-self through recognition of
sparse antigenic peptides bound to MHC molecules (pMHC) arrayed on antigen presenting cells (APC). With
remarkable specificity and sensitivity,  T lymphocytes can destroy host cells altered by viruses, other infectious
pathogens or cancerous transformations while leaving normal cellular counterparts intact. Until recently, it was
unclear how such TCR discrimination was achieved, given a lack of somatic mutations of TCR genes to boost
receptor-ligand affinity unlike with B cell receptors. Contrary to conventional ligand associations exemplified by
antigen-antibody interactions, moreover, it is now evident that physical force plays a crucial role in non-
equilibrium TCR-based T cell activation. Here we investigate the overarching hypothesis that the  T-cell
lineage receptors that recognize pMHC ligands, namely TCRs and their thymocyte-specific precursor, preTCRs,
function as mechanosensors, transducing biomechanical forces to impact thymocyte development as well as T-
cell antigen recognition, activation, and memory specification. Both TCRs and preTCRs utilize force to induce
reversible structural transitions involving clonotypic immunoglobulin (Ig)-like domains. Project 1 shall elucidate
various structural and biophysical features driving TCR mechanosensing using transformative optical
tweezers (OT)-based single molecule and single cell measurements to determine non-equilibrium dynamics and
energy landscapes under force linked to digital vs analog TCR performance. In turn, CD8 memory repertoires
against influenza A virus (IAV) epitopes arrayed at sparse to abundant pMHC ligand densities shall be compared
along with their variable domain centricities at the pMHC interface association with memory subtypes. Spatial
transcriptomics in lung tissue operating in compliant vs. non-compliant locales will be assessed using TCR B6
and retrogenic mice to understand how TCR biomechanics are optimized for selective cellular niches during IAV
infection. Project 2 shall map IAV-related preTCR and TCR structures and bond properties to thymocyte
signaling, development and repertoire diversification in thymic epithelial cultures using bulk and 10X single cell
RNAseq for complete tracking and analysis. Structural and biophysical insights will be used in conjunction with
peptide variants to sculpt the T cell repertoire to generate thymocytes expressing mature TCR IAV specificities.
Project 3 shall perform multifaceted computational analysis of TCR load propagation and conformational
dynamics to calculate stress and strain distributions across TCR-pMHC molecules during molecular dynamics
simulations under force (MDf), determine the propagation pathway and examine signal relay to CD3 subunits
and the transmembrane helices based on holoreceptor cryoelectron microscopy structures. An Administrative
Core (A), a Protein Production Core (B) and an NMR Core (C) will assist Projects to discern how force and
dynamic structures empower  T lineage recognition of pMHC with basic and translational importance.

Public health relevance
NARRATIVE – OVERALL T lymphocytes recognize host cells altered by infections or cancer-causing transformations using force applied to their surface T cell receptors to tune both cellular detection acuity and differentiation. Forces arise from T-cell motions locally (internally) or as T cells traffic through the host tissues (externally). By characterizing these force-dependent processes, we shall be able to understand and ultimately manipulate T-cell activation and memory inducing rapid recall responses, fostering protective immunity and improving immunotherapies via rational synthetic biology.